Special ProjectMethod Development and Method Validation

LFFM Project Summary - Method Development, Single Laboratory Validation The Manufactured Food Regulatory Program Standards (MFRPS) established a uniform foundation for the management of state programs responsible for the regulation of facilities including laboratory analysis for chemical and microbiological contaminants. Through this program the Georgia Department of Agriculture’s (GDA) laboratories achieved, enhanced, and maintained ISO/IEC 17025 accreditation. As part of moving this program forward the ISO testing methods must be expanded and enhanced. The GDA laboratory proposes to develop a method for the pesticide analysis of edible tree nuts for human food consumption. Currently, there are no AOAC or other standard methods for the pesticide analysis of tree nuts. Tree nuts would present a challenging food product to analyze due to the hard composition in conjunction with the presence of various oils, carbohydrates, and minerals. With millions of pounds of tree nuts consumed in food products each year tree nuts represent a ubiquitous food product important to U.S. food production and food consumption. This study would initially address pecans and then move to other important commodities like almonds and pistachios. By establishing a method, and a validation study for this analysis, samples can be examined with confidence to better to enhance Global Food Safety initiatives and protect the public by aiding in an integrated national food safety system.